An investigation of craving and cannabis misuse among young adults using multiple levels of analysis

PROJECT SUMMARY Cannabis misuse is a behavior associated with substantial negative life outcomes and is a growing public health concern. Epidemiology indicates cannabis misuse peaks during young adulthood, which has been identified as an important developmental period for intervention. Many young adults use cannabis to cope with unpleasant momentary experiences, and those who do frequently experience more substantial negative cannabis-related and mental health consequences. Based on behavioral theory, and the allostatic model (or self-medication hypothesis), current treatments for substance misuse incorporate components that focus on improving craving management, or adjusting peoples' avoidant relationship with unpleasant momentary experiences such as craving and negative affect, and have reported positive outcomes. The current proposal will investigate cross-sectional retrospective and momentary measures of craving and affect as predictors of cannabis use among young adults (Aim 1). In addition, this study will investigate hypothesized retrospective moderators to identify craving management variables, or psychological factors that affect responses to craving, that influence the relationship between craving and use (Aim 2). Finally, this study will use multilevel modeling to evaluate hypothesized momentary craving management variables that influence the relationship between momentary craving and subsequent use, as well as investigate craving as a mediator of the association between implicit risk factors and cannabis use (Aim 3). One team of investigators has reported a positive relationship between momentary craving and subsequent use among young adult cannabis users. Results from this program of research will investigate this relationship further, and enhance current prevention and treatment efforts by providing important information about craving-related variables that may influence the development and maintenance of cannabis misuse during young adulthood.

Public health relevance
PROJECT NARRATIVE By testing theories of the role of craving and craving-related variables in cannabis misuse, the proposed research will identify behavioral processes that underlie drug abuse and addiction (NIDA Strategic Goal 4), particularly how psychological variables and behavioral phenotypes influence risk and protection. The proposed program of research utilizes robust assessment methodology to develop paradigms that model the complexity of human addiction and mechanisms of abuse-related behaviors, which may bear substantial implications for enhancing interventions to change behavioral trajectories of abuse and addiction. The proposed training plan also provides crucial methodological, statistical, and ethical training for a promising researcher to continue to investigate the important relationship between craving and cannabis misuse at multiple levels of analysis.